Men's Alcohol Use and Perpetration of Sexual Aggression

DESCRIPTION (provided by applicant): Rates of sexual victimization and perpetration among college students remain disturbingly high. Alcohol is present in a large proportion of these incidents and heavy drinking patterns have been associated with both victimization and perpetration. Much of what is known about alcohol and sexual aggression is based on studies of female victims. To date, a limited amount of naturalistic research has considered the impact of men's alcohol consumption on perpetration of sexual aggression. Two studies of men are proposed to address this gap. First, using a sample of college freshmen males (N = 1700) we will examine whether men's alcohol consumption prospectively predicts sexual aggression perpetration over the next two years of college. Next, using a subsample (N = 200), we will consider the daily or temporal relationship, over 8 weeks, between episodes of alcohol consumption and sexually aggressive behavior. We hypothesize that the alcohol-sexual aggression perpetration relationship is moderated by several individual differences variables, such as sex- related alcohol expectancies, hostility toward women, and behavioral self-control. These moderators will be considered both at the distal, prospective level and at the proximal, daily level. Findings from these studies will provide significant new knowledge about the role of alcohol in men's perpetration of sexual aggression, using innovative methods. Moreover, findings can aid in the development of efficacious sexual aggression prevention programs that target men's alcohol consumption.

Public health relevance
PUBLIC HEALTH RELEVANCE: Much of what is known about alcohol and sexual aggression perpetration is based on studies of female victims, with few naturalistic studies examining men's sexually aggressive behaviors. We propose a prospective study and a daily process study to examine both the distal and proximal effects of men's alcohol consumption on their perpetration of sexual aggression. Study findings can aid in the development of efficacious sexual aggression prevention programs that target men's alcohol consumption. Much of what is known about alcohol and sexual aggression perpetration is based on studies of female victims, with few naturalistic studies examining men's sexually aggressive behaviors. We propose a prospective study and a daily process study to examine both the distal and proximal effects of men's alcohol consumption on their perpetration of sexual aggression. Study findings can aid in the development of efficacious sexual aggression prevention programs that target men's alcohol consumption. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Rates of sexual victimization and perpetration among college students are disturbingly high. Each year, approximately 5% of college women are raped (Fisher, Cullen, & Turner, 2000; Kilpatrick, Resnick, Ruggierio, Conoscenti, & McCauley, 2007), most, by men that they know. Heavy drinking patterns are associated with sexual assault perpetration and victimization, and at least half of these incidents occur while the perpetrator, the victim, or both have been drinking alcohol (see Abbey, 2002; Abbey, Zawacki, Buck, Clinton, & McAuslan, 2004; Testa, 2002 for reviews). Although it is commonly believed that men's alcohol consumption contributes to their perpetration of sexual aggression, the body of research evidence directly supporting this relationship is actually quite limited. Research on men's perpetration of sexual aggression has lagged significantly behind research on women's sexual victimization, both in quantity and sophistication. In a review of the literature, Testa (2002) concluded that whereas laboratory analog studies demonstrate alcohol effects on perceptions and intentions consistent with increased sexual aggression, there were too few survey or naturalistic studies to determine whether in fact men's drinking contributes to sexual assault perpetration. Despite some recent survey research efforts (see Abbey & McAuslan, 2004; Abbey, Parkhill, BeShears, Clinton-Sherrod, & Zawacki, 2006; Parkhill & Abbey, 2008), there is still a dearth of prospective research addressing the relationship between men's alcohol use and perpetration of sexual aggression. Moreover, there is an almost complete absence of research addressing the temporal, proximal relationship between men's episodes of drinking and subsequent perpetration of sexual aggression. Research on alcohol and women's sexual victimization has been able to establish that heavy alcohol consumption plays a causal role in victimization, suggesting the need for prevention efforts targeted toward reducing heavy episodic drinking (see Testa & Livingston, in press, for a review). Before effective prevention strategies for men's sexual aggression perpetration can be implemented, the nature of the alcohol-sexual aggression perpetration relationship and the mechanisms responsible for it need to be better understood. The proposed research will examine both the prospective and the proximal relationship between men's consumption of alcohol and their perpetration of sexual aggression. That is, we will examine whether heavy drinking men are at greater risk of perpetration of sexual aggression over the subsequent year. Moreover, we will consider whether, within individuals, an episode of intoxication increases the likelihood of sexual aggression occurring during or immediately following that episode. Mediating mechanisms and potential moderating variables will also be considered. Using a sample of male first year college students, we plan to address the following Specific Aims: 1. Is there a prospective relationship between men's alcohol consumption and subsequent perpetration of sexual aggression against women and if so, what is the strength and nature of the relationship? a. Is the relationship specific to alcohol-related aggression or is there a relationship between men's alcohol consumption and other types of sexual aggression as well? b. Is the alcohol-sexual aggression relationship moderated by individual characteristics such as sex-related alcohol expectancies, impersonal sexuality, or hostile masculinity? c. Is there a prospective relationship between men's beliefs about alcohol and sex and subsequent alcohol-related sexual aggression that is mediated via drinking in social contexts and sexual misperception? 2. Is there a proximal, daily relationship between men's alcohol consumption and perpetration of sexual aggression against women? That is, does an episode of alcohol consumption increase the likelihood of aggressive sexual behavior occurring immediately afterward? a. Does the relationship depend on the amount of alcohol consumed in the episode? b. Is the relationship moderated by individual characteristics, such as self-control, sex-related alcohol expectancies, or hostile masculinity?